The Young Empowered Scientists for ContinUed Research Engagement (YES for CURE) Program at the Dana-Farber/Harvard Cancer Center (DF/HCC)

Increasing the participation and retention of in cancer-related STEM fields is critical for improving cancer outcomes. Early engagement in scientific research has been linked to enrollment and retention of students in STEM degree programs and careers. To address issues related to workforce development including early exposure and access to cancer research related careers, the Dana-Farber/Harvard Cancer Center requests funding to support the Young Empowered Scientists for ContinUed Research Engagement (YES for CURE) Program, a multi-year, holistic, innovative, and comprehensive cancer research and education program for high school and undergraduate students in communities representing the Greater Boston catchment area. Students will participate in research training, professional skills development, career exploration, scientific curriculum, and community engagement programming. The goal of the YES for CURE Program is to engage the scientific curiosity and promote the academic success and future research careers of promising young scientists by doing so, equip our scholars with knowledge and insight to become ambassadors in their communities. The aims of the program are: 1) To engage talented and highly motivated high school and undergraduate students in mentored, hands on, cancer research experiences culminating in a presentation of their independent project. 2) To build student’s knowledge of the key concepts, decision making processes, and skills necessary for academic and professional success through participation in a year-round curriculum. 3) To develop a supportive, informed, and engaged community of culturally competent cancer scientists and science enthusiasts comprised of alumni, mentors, families, and community partners who will nurture and empower program participants. Scholars will develop and implement science and health outreach programs at middle schools that will contribute to scholar’s self-identification as competent scientific learners.
The YES for CURE Program will strive to excel in seven measurable objectives: 1. Each summer 34 students (17 per cohort) will participate in a full-time cancer research experience. 2. YES for CURE scholars will increase their knowledge of career paths and concepts and topics in cancer research, developing skills in research practices, analytical thinking, presentations, and ethics. 3. YES for CURE scholars and families will enhance their awareness of STEM research and education. 4. Scholars will develop and implement STEM curricula in their own communities. 5. YES for CURE Scholars will graduate informed and ready to progress in their STEM training. 6. At least 85% of YES for CURE participants will complete an undergraduate degree in STEM. 7. At least 50% will pursue graduate school and careers in a cancer, cancer disparities, or STEM field

Public health relevance
YES for CURE Project Narrative Increasing the participation and providing early exposure of trainees in cancer-related STEM fields is critical for improving cancer outcomes in the United States. Early exposure and engagement in scientific research has been linked to enrollment and retention of students in STEM degree programs and careers. The Young Empowered Scientists for ContinUed Research Engagement (YES for CURE) Program, in the Dana-Farber/Harvard Cancer Center, is a multi-year holistic and comprehensive cancer and cancer disparities research experience and education program for high school and undergraduate students in the Greater Boston area.